A Model for Preclinical Biomarker Discovery in Pancreatic Ductal Adenocarcinoma

DESCRIPTION (provided by applicant): Pancreatic Ductal Adenocarcinoma (PDA) is a deadly malignancy. Early systemic spread and resistance to chemotherapy combine to make PDA one of the most dismal diagnoses in modern medicine. However, hundreds of experimental anticancer medicines are now in development and could be considered for Pancreatic Ductal Adenocarcinoma (PDA). Our studies to date show that PDA can be divided into distinct subclasses that differ biologically and that may respond differently to treatment. Our goal now is to advance treatment of PDA by refining molecular descriptors of Pancreatic Ductal Adenocarcinoma (PDA), identifying therapeutic agents on the Ras pathway that are effective in specific tumors, and eventually testing these in biomarker-marker guided clinical trials. This will be accomplished through work in two aims. Aim 1 will identify and model omic determinants of response to inhibitors of the Raf-MEK-ERK and PI3 Kinase/Akt pathways in a well characterized panel of PDA cell lines. Since we suspect that combined blockade will be required, we plan to test these agents both alone and in combination. Aim 2 will validate the biomarkers of sensitivity and resistance discovered in cell lines in a selected panel of PDA xenografts resected from patients and propagated and treated in the mouse. Biomarkers identifying specific responses in both preclinical systems will be tested in biomarker-guided clinical trials with inhibitors of the Ras pathway (beyond the scope of this proposal). Overall, we expect to test the hypothesis that biomarkers identified in efficient, preclinical model system screens will prospectively identify drug responsive and drug resistant patients in clinical trials. If true, this will allow experimental drugs now under development to be quickly tested for efficacy in subclasses of PDA and then moved quickly into trials in patient subpopulations in which they are most likely to be effective. This work is 100% relevant to Pancreatic Ductal Adenocarcinoma.

Public health relevance
PUBLIC HEALTH RELEVANCE: Clinical Trials in oncology often fail because the tested drugs do not work in patients. This project will employ molecular analysis of pancreatic tumors to predict which tumors and patients will be most sensitive to certain treatments. These studies hold promise in expanding treatment options for pancreatic cancer patients, and changing the way clinical trials are conducted. Narrative: Clinical Trials in oncology often fail because the tested drugs do not work in patients. This project will employ molecular analysis of pancreatic tumors to predict which tumors and patients will be most sensitive to certain treatments. These studies hold promise in expanding treatment options for pancreatic cancer patients, and changing the way clinical trials are conducted. __SpecificAimsTextDelimiter__ 4A) Specific Aims: Pancreatic ductal adenocarcinoma (PDA) is a chemoresistant and rapidly lethal disease. This is likely due in part to the current inability to effectively intervene on signals from mutationally activated KRas, a central mutational event in PDA. Many experimental drugs on the Ras pathway (e.g. PI3Kinase/AKT/mTOR and Raf/MEK inhibitors) are now in development and could be considered for PDA, so the challenge is to identify molecular features of response for each drug such that they can be matched (alone or in combination) to tumors that will respond. Genomic analysis technologies have emerged that allow in-depth assessment of the molecular abnormalities in individual tumors and will support molecular marker driven therapy. Our studies to date already show that PDA can be divided into distinct subclasses that differ biologically and respond differently to therapeutic maneuvers including gemcitabine and KRas depletion in preclinical studies. These results begin to explain observations that a "one size fits all" approach to treatment in this disease has and will likely continue to fail. Our goal is to develop a preclinically available system to predict responses to rational, targeted therapies in PDA and to define molecular subsets of this disease with treatment ramifications. Our approach is to build response-predictors to kinase inhibitors downstream of activated KRas in a collection of PDA cell lines and to validate these predictors in primary PDA tumors grown in the mouse. In order to delineate potential responders with greatest precision, we will develop biomarker panels (i.e. predictive biomarkers) in PDA cell lines and use them to identify patient subsets likely to respond using a primary PDA xenograft system. This project is 100% relevant to Pancreatic Ductal Adenocarcinoma. Aim 1: Employ a PDA cell line panel to generate molecular biomarkers predictive of response to targeted agents downstream of activated KRas. We will test the hypothesis that coupling pretreatment cell line molecular data with in vitro cell line drug sensitivity data uncovers signatures predictive of response to targeted inhibitors downstream of KRas, both alone and in combination. Subaim 1: Develop molecular biomarkers of response to inhibition of the Raf-MEK-ERK pathway and the PI3K/Akt pathway in a PDA cell line panel. Subaim 2: Develop molecular biomarkers of response to simultaneous co-blockade of the Raf-MEK-ERK and PI3K/Akt arms of the Ras signaling network. Aim 2: Validate the predictive biomarker signatures developed in Aim 1, and/or re-derive predictive biomarkers of response de novo in vivo using primary tumors passaged as xenografts in the mouse. If cell line based predictors are to be employed clinically, they require validation. As the most proximate available system for drug response, primary tumor xenografts will be employed to this end. Should the cell line derived biomarkers fail to perform accurately in predicting in vivo response, biomarker panels will be re-derived in the xenograft system and this will become the system for future predictive biomarker generation.